Genetic Control of Retrotransposon Mobilization in the Mouse Germline

Project Summary
Retrotransposons, mainly LINEs, SINEs, and endogenous retroviruses, occupy 40% of the mammalian
genome. Retrotransposons have an enormous capacity to metastasize throughout the genome using a “copy
and paste” mechanism involving reverse transcription. While retrotransposons play an important role in
genome evolution, their mobilization can be detrimental to genome integrity. Indeed, more than 60 human
genetic diseases are caused by transposon insertion. Retrotransposons exploit the host cellular machinery to
proliferate. In response, the host has evolved multiple mechanisms to suppress retrotransposons to protect
genome integrity, particularly within the germline. The piRNA pathway is a major evolutionarily conserved small
non-­coding RNA-­based silencing mechanism for retrotransposons in germ cells. In the previous funding period,
we demonstrated that MOV10L1, a germ cell-­specific RNA helicase, is a master regulator of biogenesis of all
piRNAs in mouse. MOV10L1 interacts with all Piwi proteins and binds to piRNA precursors to initiate piRNA
biogenesis. Deficiency of Mov10l1 leads to upregulation of retrotransposons, a block in meiosis, and male
sterility. Upregulation of retrotransposon transcripts does not necessarily lead to a proportionate increase in
new retrotransposition, suggesting that additional host factors block retrotransposition. While previous studies
have made tremendous progress delineating mechanisms responsible for transcriptional and post-­
transcriptional silencing of retrotransposons, host restriction factors that prevent genomic integration of
retrotransposons in vivo have not yet been identified. Using our unique mouse models, we plan to 1)
investigate the molecular mechanism underlying the essential role of MOV10L1 in piRNA biogenesis during
spermatogenesis;; 2) elucidate the critical role of a host restriction factor in inhibition of retrotransposition in the
mouse germline;; 3) interrogate the multi-­generational impact of retrotransposon-­driven genome expansion on
genome stability, reproduction, and diseases. Completion of this project will have strong impacts on our
understanding of retrotransposon silencing, genome expansion, and etiology of human diseases including
male infertility, pregnancy loss, and birth defects.

Public health relevance
Project Narrative Retrotransposons are the most abundant repetitive elements in the mammalian genome. Insertion of retrotransposons into genes disrupts their function, resulting in a large number of human genetic diseases. Understanding retrotransposon mobilization in the germline and across generations will provide insights into genome evolution and the etiology of human diseases such as infertility, pregnancy loss, and birth defects.